Implications of Prefrontal Cortex Development for Adolescent Reward Seeking Behavior

Adolescence is a developmental period marked by increased impulsivity, heightened reward
sensitivity, and reduced behavioral flexibility. These age-typical behavioral traits are thought to arise
from ongoing maturation of brain circuits that support cognitive control and motivated behavior.
Importantly two key brain regions, the medial prefrontal cortex (mPFC) and the lateral hypothalamus
(LH), are still actively maturing during adolescence. In adults, the medial prefrontal cortex (mPFC) is
a critical brain area, guiding impulse control, decision-making, and reward-seeking. Meanwhile the
adult lateral hypothalamus (LH) is essential for driving feeding behaviors, responding to foodassociated cues, and for regulating internal states. Even though these brain regions are essential and
clearly implicated in the unique behaviors observed in adolescence, we don’t know how they are
functioning, or communicating with each other, to produce the adolescent behaviors we observe. We
hypothesis that, during adolescence, the mPFC is unable to create the neuronal representations
necessary to guide impulse control. At the same time we hypothesis that the adolescent LH, possibly
driven by metabolic demand of body growth, is supporting an increased food drive at this age, which
results in an LH that is hyperresponsive to reward-cues and may be overrepresenting reward
contexts (including generalizing neutral cues as reward associated). Together, these circuit-level
adolescent imbalances, too much “gas” (increased food drive via LH) and too little “brakes” (immature
impulse control via mPFC), result in inflexible, impulsive behavior in adolescence. In turn leading to
poor adaptability to changing task demands. To test this hypothesis, in Aim 1, we will use two-photon
calcium imaging and optogenetic to determine how task-relevant neural representations in the mPFC
evolve from adolescence to adulthood during a behavioral task that forces the individuals to suppress
reward seeking responses at the incorrect timepoints in order to obtain larger rewards. In Aim 2, we
examine the interplay between mPFC and LH activity. We test if LH hyperactivity is driving the
increased reward responsiveness and decreased impulse behavior in adolescence, and test how
mPFC-to-LH connectivity contributes to age-dependent differences in motivated behavior. By
understanding how the medial prefrontal cortex and hypothalamic circuits interact across
development, this work will provide new insight into the neural basis of adolescent-specific behavior
and identify circuit-level mechanisms that may contribute to vulnerability for psychiatric disorders such
anxiety disorders, impulse control disorders, and eating disorders that emerge during this sensitive
window.